Promoting a reparative instead of a degenerative outcome from loading of fatigue-damaged tendons

Tendinopathies are common injuries that typically result from accumulation of sub-rupture fatigue damage. We
have developed an in vivo model of sub-rupture fatigue damage accumulation using the rat patellar tendon to
investigate the onset and pathogenesis of tendinopathy. We found that just one bout of fatigue loading results in
collagen matrix damage and a 20% stiffness loss that is not recovered out to at least 10-weeks. We also found
that running exercise leads to repair when initiated 2-weeks after onset of sub-rupture fatigue injury but promotes
further degeneration when initiated 1-day after onset of injury, uniquely positioning us to determine the underlying
mechanisms necessary to develop therapeutics to transform everyday activity into a reparative stimulus. We
identified glycosaminoglycans (GAGs), specifically hyaluronan (HA) and dermatan sulfate (DS), to be increased
prior to initiation of therapeutic but not degenerative exercise. Postmortem depletion of GAGs showed that their
increase after sub-rupture fatigue injury reduces matrix shear strain and increases dynamic modulus which are
properties that are associated with modulation of proliferation, apoptosis, and αSMA differentiation. Investigation
of the repair response from therapeutic exercise identified an increase in population of αSMA+ cells and integrin
α5 (α5+/tenocytes and α5+/αSMA+ cells); an integrin that enhances the capacity of cells to withstand loads
thereby preventing cell death. Our inhibition of αSMA+ cells in therapeutic exercise increased the area of high
severity matrix damage. Blocking integrin α5 altered the morphology of αSMA and tenocytes and decreased
damage area, further enhancing the therapeutic effect of exercise. We will test the hypothesis that (1) the
increase in GAGs after onset of fatigue injury modulates the stressful mechanical environment of cells in
damaged tendons resulting from subsequent loading, leading to an increase in population of αSMA+ cells and
integrin α5 (Aim 1); (2) the increase in αSMA+ cells will largely decrease the area of high matrix damage and
that αSMA+ cells mediate tissue repair (Aim 2); and (3) that integrin α5 protects cells form apoptosis in response
to higher loading but promotes a catabolic response from the surviving α5+/tenocytes while enhancing the
functionality of α5+/αSMA+ cells (Aim 3). We will deplete HA and DS in vivo prior to initiation of therapeutic
exercise to determine their role in transforming loading into a reparative stimulus (Aim 1). Pharmaceuticals will
be used to inhibit the population αSMA+ cells (using Simvastatin in Aim 2) and to block integrin α5 (using ATN-
161 in Aim 3) to interrogate their role in promoting repair of fatigue damaged tendons. scRNAseq will be used to
compare the cell populations that are associated with repair versus degeneration of fatigue damaged tendons
and determine the effect of inhibition of αSMA+ cells and blocking of integrin α5 on these cell populations. The
proposed studies will inform diagnostics to guide management of tendon injuries by identifying the biological
environment that is associated with subsequent repair from continued use; and will inform therapeutics by
determining key biological drivers of repair that can potentially be employed independently of exercise.

Public health relevance
Tendinopathies are common musculoskeletal injuries that lead to tendon rupture and disuse. A major hurdle to progress in management of developing chronic tendinopathies is that the mechanism of tendon repair is unknown, largely because it does not naturally occur. The proposed studies will (A) identify biological and mechanical factors that should be considered prior to initiation of conservative treatment such as exercise, (B) determine the therapeutic potential of myofibroblasts and integrin α5, and (C) establish the foundation for new diagnostics and therapeutics to halt the progression of tendon damage and avoid ruptures.